Using epigenome editing of transcriptional enhancers to regulate adult visual cortical plasticity

Project Summary
The synaptic wiring diagram of the cerebral cortex is established during development, and the stability of this
network in the adult brain is important for the ability of the cortex to reliably encode information about the
sensory world. However, plasticity is also a fundamental feature of the mammalian brain, and a growing body
of evidence is revealing that even core features of neuronal response properties, such as the orientation tuning
of neurons in the visual cortex, are more dynamically plastic in the adult brain than previously thought. These
data raise the question, how is the balance between the stability and the plasticity of synaptic connections
maintained in the adult brain? Neuronal activity-dependent transcription and translation play essential roles in
the organization of cortical networks during development, and these processes contribute to long-lasting
plasticity of neuronal structure and function in the adult brain. Arc is among the most important of the activity
regulated genes during cortical development, because Arc protein functions directly at synapses to endocytose
AMPA-type glutamate receptors, inducing long-term depression (LTD) and input-specific synaptic elimination.
Genetic knockout of Arc in adult primary visual cortex impairs receptive field plasticity, whereas overexpression
of Arc enhances this plasticity. These data raise the interesting possibility that the molecular mechanisms of
activity-dependent Arc expression may act to set the balance between flexibility and stability of cortical
representations. However, no prior study has had the experimental means to selectively manipulate the
activity-dependent regulation of genes like Arc in the adult brain in order to determine the consequences for
cortical plasticity. The activity-dependent transcription of Arc is mediated by the interaction of the Arc promoter
with a distal enhancer element located ~7kB upstream of Arc. We have shown that the CRISPR-based
recruitment of dCas9-chromatin regulator fusion proteins to activity-dependent gene regulatory elements can
be used to selectively modulate the activity-dependent component of gene expression. Here in Aim 1 we will
use two novel strains of dCas9/CRISPR mice we have characterized to titrate the activity-dependent
transcription of Arc and determine the consequences for the light-dependent regulation of Arc protein
expression in the primary visual cortex (V1) in vivo. In Aim 2 we will use chronic in vivo calcium imaging
methods to assess the consequences of impairing Arc induction on the stability and plasticity of orientation
tuning in V1. Revealing such a relationship between epigenetic regulation of activity-dependent transcription
and synaptic plasticity in the adult visual cortex has the potential to transform how neuroscientists approach
the study of cortical function in health and disease.

Public health relevance
Project Narrative In the adult brain, circuits must be largely stable to retain reliable representations, but must still be flexible to account for changes to the environment or learning. These experiments will develop novel tools to investigate the transcriptional mechanisms that enable both stability and plasticity. Understanding the mechanisms that set this balance will further our understanding of cortical processing in health and disease.